Substance Use Scientific Working Group

PROJECT SUMMARY - SUBSTANCE USE SCIENTIFIC WORKING GROUP
The Texas Developmental Center for AIDS Research (D-CFAR) is based at Baylor College of Medicine
(Baylor) and University of Texas Health Science Center at Houston (UTHealth) and the Texas Biomedical
Research Institute (TxBiomed) in San Antonio. It will establish a Substance Use Scientific Working Group (SU-
SWG). Substance use trends in the state of Texas are similar to the nation as a whole in showing an increase
in opioid use and related emergency department visits and overdose deaths in recent years. Equally
concerning are recent trends in the use of methamphetamine, marijuana, cocaine, and alcohol. Substance use
and HIV are inextricably linked. Substance use is a well-established risk factor for transmission of the virus. For
people living with HIV, substance use and addiction can hasten the progression of HIV and its consequences.
Despite its significant impact on HIV, the intersection of substance use and HIV has been an underdeveloped
research area, especially in areas of the US with weaker substance use treatment infrastructures like Texas.
The proposed Texas D-CFAR SU-SWG will foster a robust research program in three areas that align with the
proposed D-CFAR to fill this gap: 1) substance use as a co-factor for transmission of HIV; 2) impact of
substance use on progression of HIV and its consequences; 3) novel treatment approaches for HIV prevention
and treatment for individuals who use substances. The SU-SWG will support research in these areas by
developing key resources, services, pilot funding opportunities, and by fostering discussions and collaborations
between Texas D-CFAR members. To achieve its goals, the SU-SWG will: 1) Work with the proposed Cores
and Core services to develop and support substance use as a critical area of research focus for ending HIV
and optimizing HIV health in Texas. 2) Inform the Texas D-CFAR community about ongoing and future
research on the intersection of substance use and HIV, both at our D-CFAR, nationally, and internationally. 3)
Inform the D-CFAR community about external funding opportunities on substance use, provide pilot project
funding opportunities through the Developmental Core, and catalyze collaborations. 4) Expand the SU-SWG
by opening membership to substance use and HIV researchers and trainees at other Texas institutions. To
achieve these aims, the D-CFAR has assembled a group of established and early stage investigators in both
HIV and substance use to bring together in the SU-SWG to foster research in the intersection of these two
epidemics. The SU-SWG includes persons with deep connections to the community and local public health
officials as well as academicians who have developed and lead innovative programs to deliver substance use
treatments. The SU-SWG leadership, in collaboration with the D-CFAR leadership, has identified a
comprehensive 5-year action plan, set of activities, policies and procedures and evaluation metrics to ensure
success. This activity organized by the SU-SWG will accelerate efforts to end HIV and improve the health of
people with HIV in Texas and beyond.